Maternal training effect on newborn cardiovascular syste

The specific aim of this protocol is to determine the level of cardiovascular function in newborns of mothers who exercised during pregnancy. This study will be carried out on 5 day old newborns delivered of healthy adult female volunteers who had an uncomplicated pregnancy and delivery and either exercised or not. At the visit data will be recorded from an m-mode ultrasound that will be used to assess cardiac volumes, mass and function as well as measures of heart rate variability to determine autonomic tone.